High-intensity drinking and related consequences: Daily data from a national sample aged 19 to 22

Project Summary/Abstract
High-intensity drinking (consuming 10+ drinks in a row) among young adults has recently been acknowledged
as a serious health problem that requires urgent research attention. During the initial grant period
(R01AA023504) we documented prevalence, predictors, and developmental change in retrospective recall of
any past 2-week high-intensity drinking from ages 18 to 30 through secondary data analysis of the national
Monitoring the Future (MTF) study. The current application is to collect new intensive longitudinal data to
examine occasion-specific predictors and consequences of binge and high-intensity drinking at the period of
the lifespan (ages 19-22) where alcohol use is the greatest. Information on occasion-specific predictors and
short- and long-term consequences of binge and high-intensity drinking is needed to identify the motives,
contexts, and public health impacts that differentiate these heavy levels of alcohol consumption. Building on
our recent findings that used biennial data from the nationally representative Monitoring the Future (MTF)
study, the current application is to conduct new primary longitudinal data collection from a national sample of
high school students followed into young adulthood. Participants (modal age 18; N=2000) from the 2018 MTF
12th-grade baseline surveys will be selected (with an oversample of high school binge drinkers) for a 4-year
web-based measurement burst study across the transition into young adulthood. Up to 56 days of data
collection per respondent will be obtained using 4 annual data collection bursts (14 consecutive days of daily
surveys per year at modal ages 19, 20, 21, and 22). Specific aims are to examine: (1) when and for whom
high-intensity drinking is most likely to occur by focusing on occasion-level predictors (e.g., affect, motives for
drinking, drinking contexts, and other substance use) and time-varying developmental predictors (e.g., college
attendance, employment, living with parents) of gender-specific rates of high-intensity drinking (8+/10+ drinks
for women/men), compared to binge (4-7 for women, 5-9 for men) or moderate (1-3 for women, 1-4 for men)
drinking occasions; (2) whether acute consequences (e.g., blackouts, injury, aggressive behavior, sexual risk,
and negative interpersonal consequences) associated with high-intensity (compared to moderate and binge)
drinking differ across days and based on developmental and sociodemographic characteristics; and (3) longer-
term patterns of alcohol-related consequences (ages 18-22) and whether they differ by gender and social roles
including educational experiences (e.g., 2-year and 4-year college). The project will be the first national study
of both college attenders and non-attenders to identify occasion-level predictors and occasion-level
consequences of specific occasions of binge and high-intensity drinking. This will provide critical information for
health promotion and intervention efforts targeting high-risk alcohol behaviors among young adults.

Public health relevance
Project Narrative This research project will be the first to examine the occasion-level predictors and consequences of high- intensity drinking (consuming 8+/10+ drinks in a row for women/men) among young adults in a new longitudinal data collection study sampled from a nationally representative cohort of 12th graders. We will document occasions when high-intensity drinking is most likely to occur, short-term consequences of high- intensity drinking occasions (compared to other drinking occasions), and patterns of high-intensity drinking and drinking problems across the transition into young adulthood among college attenders and non-attenders. The primary goals of this study are to provide new and needed information regarding occasions when and for whom high-intensity drinking occurs and leads to serious negative consequences among US young adults.